EFFECTS OF NITRIC OXIDE INHAL ON PHYSIOL DEADSPACE IN PRETERM INFANTS WITH RDS

The purpose of this study is to determine if inhaling nitric oxide can make breathing easier by improving both the delivery of oxygen to the infant and release carbon dioxide.